Establishing the dynamics of lymphoid clonal hematopoiesis and its aging-related disease consequences

Project Summary
With age, dividing cells acquire DNA mutations. A small number of these somatic mutations confer a selective
advantage leading to a clonal proliferation of cells harboring the somatic mutation. In blood, this process is
termed ‘clonal hematopoiesis’. These mutations include both point mutations in cancer driver genes (eg. clonal
hematopoiesis of indeterminate potential ‘CHIP’) and megabase-scale deletions, duplications and copy-neutral
loss-of-heterozygosity (eg, mosaic chromosomal alterations, ‘mCAs’). CHIP and mCAs have each been
detected in ~5% of individuals over 60. While both predict shorter lifespans, CHIP leads to a myeloid biased
stem cell differentiation while mCAs lead to a lymphoid biased stem cell differentiation. As a result, CHIP and
mCAs have distinct disease associations with infection, cardiovascular disease, cancer and other diseases of
aging. Although CHIP has been an area of significant research activity, multiple gaps persist in our knowledge
of mCAs and their impacts on aging and population health. mCA clones that expand to make up a larger
proportion of the blood predict worse health consequences. However, we do not know why some mCA clones
but not others expand, what factors predict the rate of clonal expansion and how rate of expansion associates
with disease outcomes. Overall, we hypothesize that mCAs with higher rates of clonal expansion confer a
greater impact on health and that the propensity to expand has genetic and environmental underpinnings that
are mediated through gene expression. A barrier to addressing this gap is a paucity of large well-annotated
collections of longitudinally-sampled blood. Fortuitously, our team has two recent accomplishments that enable
us to address this gap: 1) a survey of mCAs in 67,000 whole genomes and 2) development of a novel
computational method to estimate the rate of mCA expansion from single timepoints. In Aim 1, we will
measure the rate of mCA expansion by leveraging unique serial blood samples (collected up to 19 years apart)
from 729 individuals with mCAs from three deeply phenotyped cohorts. In Aim 2, we will refine our method for
clonal expansion rate estimation and apply this method at population scale to estimate mCA clonal expansion
rates in 1.3 million individuals from several diverse cohorts. We will identify genetic and environmental factors
predisposing to clonal expansion and establish the relationship between mCA clonal expansion and disease. In
Aim 3, we will analyze bulk and single-cell RNA-sequencing to ascertain the cell type specific biological impact
of mCAs and identify pathways leading to clonal expansion. Our multidisciplinary team with deep expertise in
computational genomics, statistics, hematology and human epidemiology is uniquely poised for success in this
effort. Successful execution of our aims will inform risk models to stratify individuals with mCAs for
personalized prevention, such as interventions or enhanced screening, and identify new biological pathways to
target for therapeutic development. Finally, our study serves as a model for insights on somatic mosaicism in
other tissues and disease sites beyond the blood to support healthy aging and improve population health.

Public health relevance
Project Narrative Mutations to DNA acquired during the lifetime of an organism may accumulate and result in a tendency for the groups of cells, or clones, that harbor them to grow faster and thus expand. Such clones, including those with alterations to their chromosomes such as deletions or duplications of DNA, are detected in the blood of >5% of older individuals and cause increased mortality through increased risk of cardiovascular disease, infection, cancer, kidney disease and lung disease. We will use genomics and computational approaches to estimate the rates at which these clones are expanding in 1.3 million individuals to understand the molecular causes and consequences of expanding clones on aging health and disease.